Understanding Ethnic Differences in Cancer: The Multiethnic Cohort Study

PROJECT SUMMARY / ABSTRACT
In Alzheimer's disease (AD) research to mitigate the disease burden, there is a critical need to better utilize
prospective cohorts. The need is especially great for population-based cohorts that include significant numbers
of racial/ethnic minority individuals. In light of this, we initiated AD and related dementias (ADRD) research in
the Multiethnic Cohort Study (MEC; 1993-current), the largest and most diverse cancer cohort in the US,
composed at baseline of >215,000 adults of five ancestries (African, Japanese, Latino, Native Hawaiian, White)
sampled in Hawaii and Southern California. We observed that the AD rates and the known risk factor
associations in the MEC-Medicare linkage data are highly comparable to those reported in clinic-based studies,
which assures the quality and generalizability of the MEC data for AD/ADRD research. We also found
substantially higher AD risks and APOE e4 frequencies among Native Hawaiians as well as African Americans,
compared to Whites. This and other important findings speak to the unique values of the MEC for AD/ADRD
disparities research. However, one recurrent concern is that the AD/ADRD definitions in MEC are solely based
on Medicare claims and, thus, may include misclassifications. Medicare claims-based disease outcomes are
validated against clinical diagnosis. This approach is, however, less reliable for AD/ADRD because the current
diagnostic gold standard, neuroimaging or cerebrospinal fluid biomarkers, is often inaccessible or intolerable,
particularly to individuals of racial/ethnic minorities, rural residences and older ages, while clinical assessment
without these biomarkers has known low accuracy. In this context, the blood-based maker (BBM) newly
approved by FDA for initial screening of AD, phosphorylated tau-181 (pTau-181), provides a vital opportunity to
robustly validate AD cases in MEC, while at the same time producing timely evaluation of the BBM by
race/ethnicity. Thus, we propose to (Aim 1) replicate the association between plasma pTau-181 and ~570
incident AD cases using archived blood collected within 5 years of the first Medicare claim in a nested case-
control study. We will evaluate the association overall and by sex, race/ethnicity and APOE e4. We will also (Aim
2) identify the determinants of plasma pTau-181 in AD cases, among the case-related, demographic (sex,
race/ethnicity, age cohort, education, neighborhood socioeconomic status), genetic (APOE, polygenic risk score)
and modifiable risk factor (vascular-metabolic disease history, physical activity, diet quality, sleep duration)
characteristics available from the long-term, prospective follow-up, in order to understand the biomarker variation.
The proposed work is within the scope of the active MEC grant (U01 CA164973; 2022-2027), as it will enhance
the cohort infrastructure for investigations of genetic, lifestyle and environmental risk factors for an important
chronic disease in US adults across multiple racial/ethnic groups. Given the breadth and depth of the cancer and
other chronic disease research that has been supported by the MEC, this proposed BBM-based validation and
investigation of AD is likely to stimulate an array of additional activities leading to progress on AD/ADRD research.

Public health relevance
PROEJCT NARRATIVE We propose to analyze a recently FDA-approved, highly accurate blood-based maker (BBM) of Alzheimer's disease (AD) in the archived blood of the Multiethnic Cohort for AD cases and healthy controls. We will confirm the BBM is elevated among AD cases compared to controls, which would validate the Medicare claims-based cases. We will also compare the BBM levels and the relationship between the BBM and AD by sex, race/ethnicity (across African American, Japanese American, Latino, Native Hawaiian, and White groups) and individual genetic susceptibility.